BEHAVIORAL AND PHYSIOLOGICAL EFFECTS OF 2-DEOXYGLUCOSE INFUSIONS

2-deoxyglucose (2-DG) is a glucose analog which competitively inhibits glucose-6-phosphate dehydrogenase and leads to intracellular glucoprivation. In previous studies, 2-DG has been used as a stressor to activate both the hypothalamic-pituitary-adrenal (HPA) axis and the sympathetic adrenal axis and stimulate the appetitive centers of the hypothalamus. Our interest in this paradigm was generated by our clinical observation that alcoholics frequently consume increased amounts of carbohydrates following cessation of drinking. In order to explore possible hypothalamic abnormalities in subjects with alcoholism, we administered 2-DG to abstinent alcoholics that were classified into Type I and Type II subgroups using von Knorring's criteria. In this study we explored the behavioral and physiological changes arising from the 2-DG challenge. We postulated that a 2-DG induced glucoprivic response would give rise to both neuroendocrine and behavioral changes that might elucidate mechanisms of alcohol's action in the hypothalamus. Preliminary analysis of the results show alcoholics consume less calories than controls following both 2-DG and placebo administration. However, of interest alcoholics consume more carbohydrate than controls. The neuroendocrine responses are currently being assayed.